Leadership Group

PROJECT SUMMARY/ABSTRACT—LEADERSHIP GROUP
The leadership group (LG) will provide strategic and operational direction to the Center. The LG consists
of a director, a senior project manager, the disease-specific group leaders, the centralized group leaders, an
operations team, and various other Center committees. DAIT staff representing each of the three disease
areas, bioinformatics, regulatory, and statistics (as needed) will also be considered part of the larger, external
leadership group.
The proposed LG steering committee provides consistency and clear communication across multiple
studies and functional groups. The LG structure is designed to meet the following primary objectives:
• Centralize and facilitate open lines of communication between Center group leaders and DAIT
• Standardize processes and procedures across the entire program
• Address high-level issues regarding study design, implementation, and analysis
• Keep the Center current with industry and NIH standards
• Provide administrative support to the Center
• Allocate resources across the Center
• Manage the financial aspects of the Center
Members of the LG will build on our past success with coordinating DAIT studies to develop effective
collaboration and communication channels for the Center. These same channels will be used for decision-
making and issue resolution. We have found through our work with large multi-protocol NIH coordinating
centers that effective communication requires a combination of approaches, including scheduled and ad hoc
meetings and teleconferences, use of a collaboration portal to share documents and status information, and
other tools and processes we have developed over time.
Ongoing monitoring and tracking of LG functions and progress is essential to maintaining timely, high
quality work across the Center. Activities must be monitored at the group level and across the Center. The LG
director and senior project manager assume responsibility for monitoring work across the Center.
With the goal of providing all stakeholders with the information needed to evaluate progress and identify
issues and monitor resources, Rho utilizes a number of standard processes, tools, and activities that can be
tailored to the needs of individual projects. As new needs arise, Rho refines these items to continuously
improve our tracking and monitoring methods.